Study of a new driver and therapeutic vulnerability of bone metastasis

Current therapeutic interventions remain largely palliative in patients with bone metastases. For instance,
treatment with zoledronic acid or denosumab can inhibit bone resorption, reduce the risk of skeletal-related
events, and alleviate bone pain; however, their clinical use for bone metastasis is insufficient. Our research
addresses the urgent need to transform bone metastasis treatment by exploring a new driver and therapeutic
vulnerability of bone metastasis. Leveraging an in vivo positive selection system based on CRISPR activation,
we conducted a forward genetics screen that led to the discovery of a bone metastasis driver, acyl-CoA binding
protein (ACBP), whose role in cancer metastasis has not been reported previously. In preliminary studies,
overexpression of wild-type ACBP, but not the acyl-CoA-binding deficient mutant, in non-metastatic and weakly
metastatic cancer cells stimulated fatty acid oxidation (FAO) and bone metastasis. Conversely, knockout of
ACBP in highly bone-metastatic breast cancer cells abrogated metastatic bone colonization. Moreover,
overexpression of ACBP in cancer cells boosted the production of ATP and NADPH, reduced levels of reactive
oxygen species, and inhibited lipid peroxidation and ferroptotic cell death (ferroptosis). Notably, we found a
significant correlation of ACBP expression with metabolic signaling, bone metastases, and poor clinical
outcomes. Building upon our preliminary findings, we will study the function and mechanism of action of ACBP
in breast cancer bone metastasis, as well as its therapeutic potential. Specifically, we will test the hypothesis
that ACBP promotes bone metastasis by regulating lipid metabolism – stimulating FAO while protecting against
lipid peroxidation and ferroptosis. In addition to tumor cell-autonomous effects, we will investigate ACBP’s role
in intercellular communication, such as whether bone marrow adipocytes transfer fatty acids to ACBP-expressing
breast cancer cells and whether ACBP propagates FAO activation between tumor cells. Moreover, we will
examine the impact of ACBP on the tumor microenvironment at primary and bone-metastatic sites, focusing on
the recruitment of specific populations of immune cells and stromal cells. Further, we will explore whether
blocking FAO or neutralizing ACBP through targeted therapeutic agents can inhibit breast cancer bone
metastasis. If successful, this project could illuminate new pathways through which tumor cells adapt to and
thrive in the bone, providing insights that may guide the development of novel therapies targeting bone
metastasis in breast cancer and other cancers.

Public health relevance
Understanding and targeting the molecular underpinnings of bone metastasis remains one of the most pressing challenges in cancer treatment. Our discovery of ACBP as a previously undescribed bone metastasis driver demonstrates the power of in vivo forward genetics screening and uncovers the pivotal role of lipid metabolism in tumor cell adaptation to and thriving in the bone microenvironment. The successful completion of this project will reveal novel targets for the treatment of bone metastases.